Alabama Department of Public Health Maintaining Conformance of MFRPS

ALABAMA DEPARTMENT OF PUBLIC HEALTH
COOPERATIVE AGREEMENT APPLICATION AND JUSTIFICATION FOR
MFRPS MAINTENANCE FUNDS
PROJECT SUMMARY
The Cooperative Agreement is to provide funding for the ADPH state manufactured
foods program to maintain conformance with the most current version of FDA’s
Manufactured Food Regulatory Program Standards (MFRPS) national standards.
PURPOSE
To provide adequate staffing, with funding for travel and other requirements as needed,
to review and inspect each food manufacturing firm in Alabama jointly with the county
Public Health Environmental staff. By having adequate specialized staff, ADPH will be
able to work toward maintaining conformance with the MFRPS National Standards as
part of an integrated food safety system.
PROPOSAL IN GENERAL
ADPH will use funds provided by FDA through this funding opportunity to work towards
completion of the implementation and maintaining conformance with the most current
version of the MFRPS. This will be done in the format of working on completion and
conformance of each Standard, by the target date of June 30, 2026. This proposal
delineates each standard and the work to be done throughout the 3-year program to
achieve full implementation and maintain conformance with the national standards.

Public health relevance
ALABAMA DEPARTMENT OF PUBLIC HEALTH COOPERATIVE AGREEMENT APPLICATION AND JUSTIFICATION FOR MFRPS MAINTENANCE FUNDS PROJECT NARRATIVE The Cooperative Agreement is to provide funding for the ADPH state manufactured foods program to maintain conformance with the most current version of FDA’s Manufactured Food Regulatory Program Standards (MFRPS) national standards. It will provide adequate staffing, with funding for travel and other requirements as needed, to review and inspect each food manufacturing firm in Alabama jointly with the county Public Health Environmental staff, coordinating enforcement. By having adequate specialized staff, ADPH will be able to work toward maintaining conformance with the MFRPS National Standards and participate in the national integrated food safety system.